Washington University Institute of Clinical and Translational Sciences (TL1)

Contact PD/PI: Powderly, William G. NRSA-Training-001 (075)
J. NRSA Training Core (TL1), 7. Project Summary/Abstract
Washington University School of Medicine has a robust research infrastructure, outstanding faculty mentors,
well-developed clinical and translational research (CTR) training programs, and a large and diverse pool of
excellent pre- and postdoctoral candidates. The objective of the TL1 is to ignite an interest in becoming a CTR
scientist and provide the research experience, coursework, and career development opportunities to achieve
this goal. Over the past 15 years, the TL1 has successfully trained predoctoral MD, PhD, and allied health
doctoral students. For our last competitive renewal, we added postdoctoral trainees interested in
entrepreneurship, technology transfer, and intellectual property development. We now propose to expand our
program to add support for a mentored career development pathway for MD clinical fellows. We describe new
innovative curricula in biomedical informatics, dissemination and implementation (D&I) science, community
engagement, team science, health equity, and online initiatives. We will introduce new mentor training
programs coordinated by the Clinical Research Training Center. We request annual funding for 5 predoctoral
and 7 postdoctoral trainees for 1-2 years.
The overall aims of the TL1 Program are:
Aim 1: Enhance TL1 infrastructure and programs to provide outstanding clinical and translational
research training opportunities for predoctoral and postdoctoral trainees.
Aim 2: Develop competency-based, personalized learning opportunities for diverse trainees focused
on conducting and integrating translational research in populations and across the lifespan.
Aim 3: Engage diverse trainees, community stakeholders in multidisciplinary collaborative clinical and
translational research to accelerate the benefit and impact of translational science.
Aim 4: Provide high–quality comprehensive informatics training.
Aim 5: Perform robust tracking and evaluation of TL1 program, trainees, and alumni, and use these
data to improve the TL1 program.
Trainees will engage in a mentored research experience with one of 74 experienced program faculty, complete
CTR coursework, and engage in career development activities. This award period will focus on expanding
training opportunities and increase recruitment of trainees from diverse backgrounds. The TL1 Program fills a
critical niche at WUSM and our partners through its multidisciplinary focus on clinical and translational
research, and unique emphasis on entrepreneurship, D&I, community engagement, and health equity. We will
also work with the CTSA consortium to share curriculum, training, career development programs, and methods
and tools to continually improve and provide outstanding CTR training in the future.
Project Summary/Abstract Page 1517
Contact PD/PI: Powderly, William G. NRSA-Training-001 (075)
J. NRSA Training Core (TL1)
9. Bibliography and References Cited
1. https://clic-ctsa.org/news/insights-inspire-making-commitment-diversity-inclusion.
2. Bastian M, Heymann S, Jacomy M. Gephi: An Open Source Software for Exploring and Manipulating
Networks. Proceedings of the International AAAI Conference on Web and Social Media. 2009 03/19;3(1).
3. Abedin Z, Biskup E, Silet K, Garbutt JM, Kroenke K, Feldman MD, McGee R, Jr., Fleming M, Pincus HA.
Deriving competencies for mentors of clinical and translational scholars. Clin Transl Sci. 2012 Jun;5(3):273-80.
PMCID: PMC3476465.
4. Keyser DJ, Lakoski JM, Lara-Cinisomo S, Schultz DJ, Williams VL, Zellers DF, Pincus HA. Advancing
institutional efforts to support research mentorship: a conceptual framework and self-assessment tool. Acad
Med. 2008 Mar;83(3):217-25.
5. https://cimerproject.org/entering-mentoring/
6. Meagher E, Taylor L, Probsfield J, Fleming M. Evaluating research mentors working in the area of clinical
translational science: a review of the literature. Clin Transl Sci. 2011 Oct;4(5):353-8. PMCID: PMC3727275.
7. Nearing KA, Nuechterlein BM, Tan S, Zerzan JT, Libby AM, Austin GL. Training Mentor-Mentee Pairs to
Build a Robust Culture for Mentorship and a Pipeline of Clinical and Translational Researchers: The Colorado
Mentoring Training Program. Acad Med. 2020 May;95(5):730-736. PMCID: PMC7644265.
8. Milewicz DM, Lorenz RG, Dermody TS, Brass LF. Rescuing the physician-scientist workforce: the time for
action is now. J Clin Invest. 2015 Oct 1;125(10):3742-7. PMCID: PMC4607120.
9. Salata RA, Geraci MW, Rockey DC, Blanchard M, Brown NJ, Cardinal LJ, Garcia M, Madaio MP, Marsh JD,
Todd RF, 3rd. U.S. Physician-Scientist Workforce in the 21st Century: Recommendations to Attract and
Sustain the Pipeline. Acad Med. 2018 Apr;93(4):565-573. PMCID: PMC5882605.
10. https://acd.od.nih.gov/documents/reports/PSW_Report_ACD_06042014.pdf.
11. Daye D, Patel CB, Ahn J, Nguyen FT. Challenges and opportunities for reinvigorating the physician-
scientist pipeline. J Clin Invest. 2015 Mar 2;125(3):883-7. PMCID: PMC4362227.
12. Williams CS, Iness AN, Baron RM, Ajijola OA, Hu PJ, Vyas JM, Baiocchi R, Adami AJ, Lever JM, Klein PS,
Demer L, Madaio M, Geraci M, Brass LF, Blanchard M, Salata R, Zaidi M. Training the physician-scientist:
views from program directors and aspiring young investigators. JCI Insight. 2018 Dec 6;3(23). PMCID:
PMC6328016.
13. Marsh JD, Todd RF, 3rd. Training and sustaining physician scientists: what is success? Am J Med. 2015
Apr;128(4):431-6.
14. Permar SR, Ward RA, Barrett KJ, Freel SA, Gbadegesin RA, Kontos CD, Hu PJ, Hartmann KE, Williams
CS, Vyas JM. Addressing the physician-scientist pipeline: strategies to integrate research into clinical training
programs. J Clin Invest. 2020 Mar 2;130(3):1058-1061. PMCID: PMC7269558.
15. Blish CA. Maintaining a Robust Pipeline of Future Physician-Scientists. J Infect Dis. 2018 Aug
14;218(suppl_1):S40-s43. PMCID: PMC6093428.
16. Titanji BK, Swartz TH. A Diverse Physician-Scientist Pipeline to Fight Structural Racism. Clin Infect Dis.
2020 Sep 14.
17. Luke DA, Sarli CC, Suiter AM, Carothers BJ, Combs TB, Allen JL, Beers CE, Evanoff BA. The
Translational Science Benefits Model: A New Framework for Assessing the Health and Societal Benefits of
Clinical and Translational Sciences. Clin Transl Sci. 2018 Jan;11(1):77-84. PMCID: PMC5759746.
18. https://news.stlpublicradio.org/health-science-environment/2017-08-31/seek-first-to-understand-lessons-
on-poverty-teach-medical-students-to-be-better-doctors#stream/0.
19. https://www.teamscience.net/home.
20. Hesse BW. COALESCE (CTSA Online Assistance for Leveraging the Science of Collaborative Effort).
JAMA. 2011;306(17):1925-1926.
References Cited Page 1518